Gut bacterial O-demethylation

The gut microbiota has increasingly been recognized as a xenobiotic-metabolizing organ involved in drug
bioactivation/inactivation and elimination. Changes in gut bacterial composition and/or the activity of gut
bacterial drug-metabolizing enzymes may change systemic exposure to drugs and thus increase the incidence
of adverse drug reactions. In this proposal, we aim to define a previously unappreciated gut bacterial O-
demethylation as a potential drug-metabolizing pathway for compounds containing the methoxylated aromatic
ring(s). Various botanical compounds undergo gut bacterial O-demethylation, but it was completely unknown
whether drugs are also subject to gut bacterial O-demethylation. In our preliminary study, we showed that
several gut bacteria known to O-demethylate botanical substrates catalyze the O-demethylation of an oral
anticancer drug etoposide, producing a less active metabolite M1. Moreover, we have found that systemic
exposure to orally administered etoposide is 2-fold higher in mice pre-treated with non-absorbable antibiotics,
while M1 systemic exposure is 3-fold lower in the mice. These results indicate that gut bacterial O-
demethylation contributes significantly to the pre-systemic elimination of etoposide. We also identified a new
gut bacterium previously unknown for O-demethylation activity. Expanding our findings in preliminary studies,
we aim to obtain the landscape of gut bacterial O-demethylation by testing ~70 drug compounds containing O-
methylated aromatic rings for O-demethylation (Aim 1) and by identifying and characterizing gut bacterial O-
demethylases (Aim 2). The proposed research will establish new paradigms in our understanding of xenobiotic
metabolism by gut bacteria as well as drug interactions involving gut bacterial O-demethylation.

Public health relevance
Drug handling in the bodies is influenced by multiple factors such as diet and co-administered drugs, and this causes adverse drug reactions in certain individuals. We propose to study how gut microflora may chemically modify drugs taken orally to better understand the effects of diets or co-administered drugs on drug therapy. The knowledge obtained from this study can help us better predict changes in drug responses in different individuals and thus prevent potential adverse drug outcomes.